The MUC2 Mucus Gel as an Innate Immune Mechanisms that Inhibits Colitis

DESCRIPTION (provided by applicant): The mucus covering our mucosal surfaces is an intimate part of the innate immune system and the first line of defense against microbial challenges. This is especially prominent in the lower parts of the intestine where we have to protect ourselves at the same time as we live in a symbiotic relation without trigger an overt immune response. In a trend-setting publication (PNAS, 2008) we could shown that colon has a double- layered mucus layer built around the MUC2 mucin. The inner of these act as a barrier and does not allow bacteria to penetrate. With an absence of MUC2 or defects in the mucus, bacteria reach the epithelial cells, penetrate into the crypts, and into the epithelial cells. In experimental colitis the bacteria can penetrate this inner dense mucus layer further proving that this is the key to an understanding of intestinal inflammation and ulcerative colitis. We will now study how the mucus layers are formed and built by the use of biochemical methods, especially mass spectrometry, and the use of various types of gene knock-out animals that are colonized with bacteria or germ-free. By studies on the growth of the mucus layers from biopsies we will characterize the alterations causing ulcerative colitis. The mucus properties will be manipulated by recombinant mucus proteins and pharmacological agents. Expected results are novel ways to improve the protection of colon and by this novel principle for treatment of the disease ulcerative colitis. Aim 1. To obtain a functional understanding of how the mucus and its main component, the MUC2 mucin, protect the mucosal surfaces of the colon and small intestine. Secretion, formation and components of the loose and firm colonic mucus in the large intestine and its transition This includes an understanding of biosynthesis, 0-glycosylation, unpacking/secretion, volume expansion, attachment to epithelia, and regulation by immune system. Aim 2. To unravel the role of the MUC2 mucin and its glycans in the selection of our colonic commensal bacterial flora and effects of bacteria on the inner mucus layer. Aim 3. To unravel the role of the inner colonic mucus layer in the disease Ulcerative Colitis (UC). PUBLIC HEALTH RELEVANCE (provided by applicant): Ulcerative colitis is a relatively common disease that causes personal suffering as well as high costs for the health care system. Our discovery of an inner mucus layer in colon that separates the large amount of bacteria in the colon from the epithelial cells has provided a new model for the initiation of this disease as we know that defects in this barrier and epithelial contact with bacteria triggers inflammation as observed in this disease

Public health relevance
(provided by applicant): Ulcerative colitis is a relatively common disease that causes personal suffering as well as high costs for the health care system. Our discovery of an inner mucus layer in colon that separates the large amount of bacteria in the colon from the epithelial cells has provided a new model for the initiation of this disease as we know that defects in this barrier and epithelial contact with bacteria triggers inflammation as observed in this disease